SEROTONIN FUNCTION IN PATIENTS WITH EATING DISORDERS AND IN HEALTHY CONTROLS

Evaluates whether administration of the serotonin agonist fenfluramine is useful in the treatment of bulimia nervosa and anorexia nervosa.